6th International gamma delta T-cell conference

DESCRIPTION (provided by applicant): The sixth, biennial ?? T Cell Conference will be held on May 16-18, 2014 at the University of Illinois College of Medicine conference center in Chicago, IL. The goals of the conference are to bring together investigators from around the world working in ?? T cell biology to discuss unpublished results, develop new paradigms and directions for future research, highlight and encourage junior investigators, establish collaborations and facilitate sharing of resources. ?? T cells play unique roles in tissue homeostasis, defensive response to infection, tissue repair, inflammation and tumor killing. Recent translational research studies and results from clinical trials demonstrate novel approaches to utilize ?? T cells for immunotherapeutic treatment of patients with a variety of malignancies. The International ?? T Cell Conference is held every 2 years and is the only forum for presentation and discussion of cutting-edge advances in basic to translational work that is focused on ?? T cells. Topics that will be covered in the conference include ?? TCR development and structure, antigens and ligands for ?? T cells, coreceptor and costimulatory molecules for ?? T cell function, specialized roles of ?? T cells in tissue repair and inflammation, function of ?? T cells in malignancy, infectious and autoimmune diseases, and immunotherapy with ?? T cells. Although the majority of the speakers will be selected from abstracts, commitments for participation have been obtained from the organizing committee, session chairs, discussion leaders and key speakers who are leaders in the field including women, minorities, and junior investigators. Funds are requested to provide support for travel awards for trainees and rental fees for conference space, poster displays, audio visual equipment and technical assistance.

Public health relevance
PUBLIC HEALTH RELEVANCE: ???T cells play key roles in tissue homeostasis, inflammation, tissue repair, and anti-viral and anti-tuberculossis responses, plus they have potent anti-tumor activity providing support for clinical trials to determine if ?? T cells can be used for immunotherapy in various malignancies. The s, biennial ?? T Cell Conference will be held on May 16-18, 2014 at the University of Illinois College of Medicine conference center in Chicago, IL to provide a unique and exciting forum for discussion of the latest advances in the field.